Neuroimaging in Pregnancy to Assess Effects of Opioid Use Disorder

Project Summary: Opioid use disorder (OUD) in pregnant American women is a major and growing public
health concern. Despite medication treatment for OUD with buprenorphine, these pregnant women continue to
be at high risk for early relapse, polysubstance use and depression worsening their and their children’s
outcomes. We and other investigators have previously shown altered brain resting state functional MRI (rs-fMRI)
connectivity in infants with prenatal opioid exposure that correlate with outcomes. However, there are no
neuroimaging studies in pregnant women with OUD to understand the neurobiological effects of OUD,
buprenorphine dose response and effects of concomitant polysubstance use in pregnant women. In pregnant
women on buprenorphine OUD, there is variability in dose escalation and requirement to prevent withdrawal
symptoms and craving due to increasing body weight and variable upregulation of buprenorphine metabolic
pathways. Individual variability to buprenorphine metabolism may underlie variations in treatment response and
individual poor neurobiological outcomes including postpartum relapse and depression. Our research is focused
on fulfilling the critical unmet need to better understand the structural and functional brain alterations in
pregnancy that correlate with buprenorphine treatment doses and plasma exposures to optimize maternal OUD
outcomes. The objective of this application is to characterize OUD-related prenatal maternal brain structural and
rs-fMRI alterations, and how buprenorphine treatment influences these alterations identified on neuroimaging.
The specific aims of our project are to assess OUD related alterations in maternal brain structure and rs-fMRI
connectivity in pregnant women and assess the associations of maternal brain structural and rs-fMRI connectivity
alterations with plasma buprenorphine in pregnant women with OUD. This proposal is expected to provide
critical new knowledge on the impact of buprenorphine treatment on maternal brain, and insight into the impact
of individual buprenorphine metabolism upregulation in pregnancy on these brain alterations. Eventually, these
results will help develop maternal neuroimaging as a potential prognostic tool for early identification of maternal
and infant outcomes.

Public health relevance
Project Narrative Pregnant women on opioid maintenance therapy using buprenorphine have better short-term outcomes in the mother and infant than untreated women, but negative outcomes including neonatal drug withdrawal and relapse in the mother after delivery are still present. In this project we will study the structure and function of the maternal brain in pregnancy in women on buprenorphine treatment and how they relate to buprenorphine levels. Results of this study will help us design future methods for early identification and prevention of poor pregnancy outcomes in these women with opioid use disorder and improve health outcomes in their infants.